cGMP Compliant HPLC for Radiopharmaceutical Quality Control

Project Summary
This application requests funds to purchase a modern, cGMP-compliant high-pressure liquid
chromatography (HPLC) system for use in quality control of radiopharmaceuticals; to be housed,
managed, and utilized as a Shared Resource within the Vanderbilt University Institute of Imaging
Science (VUIIS) Radiochemistry Core Laboratory. This Core resource allows access to research
radiotracers for use on three human PET/CT imaging systems, two pre-clinical PET imaging
systems and a variety of other end uses. The system will be utilized by researchers at Vanderbilt
University and Vanderbilt University Medical Center, as well as being available for use by
investigators at the nearby VA and Nashville’s Meharry Medical College, an HBCU that is one of
the nation’s oldest and largest historically black academic health science centers. The proposed
equipment is a Lablogic Logi-CHROM system with quaternary pump, thermostatic column
compartment, auto-sampler, UV and gamma detectors. In addition to providing software
specifically designed to be compliant with 21 CFR 11 and 21 CFR 212, the system’s diode array
detector is particularly attractive as it will allow for monitoring of multiple UV wavelengths
simultaneously. The proposed equipment will greatly enhance the existing NIH-supported clinical
and preclinical research projects that utilize positron emission tomography (PET), single photon
emission computed tomography (SPECT), and therapeutic radiopharmaceuticals.

Public health relevance
Project Narrative This application requests funds to purchase a modern, cGMP-compliant high-pressure liquid chromatography (HPLC) system for use in quality control of radiopharmaceuticals. Radiopharmaceuticals prepared using this equipment will be either used to non-invasively detect disease and measure response to therapies, or as radiotherapies in human beings and preclinical models.